Epigenetic Mechanisms of Chronic Stress Action

PROJECT SUMMARY:
This is a revised version of a new R01 grant that characterizes stable epigenetic changes that are induced in
mouse limbic brain regions in response to early life stress (ELS) which then increase an individual's
susceptibility to subsequent stress for a lifetime. This work has been supported over the past ten years by an
NIMH Conte Center, however, that Center has now “sun-setted”—it cannot be renewed—hence, this new
proposal to continue this original line of research. Our innovative hypothesis is that ELS induces stable
“chromatin scars” that drive long-lived changes in gene expression, which then mediate downstream changes
in cell and circuit function and ultimately behavioral responses to chronic stress in adulthood. We concentrate
on nucleus accumbens (NAc) based on its central role in brain reward and motivation and on empirical findings
of its central role in controlling stress susceptibility. We utilize open-ended, unbiased proteomic and next-
generation sequencing approaches to first identify the most robust and significant putative chromatin scars in
NAc in a cell-type-specific manner and to then characterize those mechanisms at the molecular, cellular, and
behavioral levels. Importantly, we investigate only those mechanisms that are validated in postmortem NAc of
depressed humans. One major focus is H3K79me2 (dimethylation of Lys79 of histone H3), the induction of
which is the most significant histone modification caused by ELS in NAc of both male and female mice. The
methyltransferase (DOT1L) and demethylase (KDM2B) that control H3K79me2 are both induced in NAc by
ELS, effects specific to D2-type medium spiny neurons (MSNs). Bidirectional viral-mediated manipulation of
DOT1L or KDM2B selectively in D2 NAc MSNs of male and female mice establishes the role played by these
enzymes in mediating the ability of ELS to increase stress susceptibility based on rapid behavioral screening
assays. We will now extend measures of stress susceptibility to numerous, more sophisticated behavioral
procedures with greater translational potential, and test the ability of a DOT1L inhibitor, now in clinical trials for
certain cancers, to reverse ELS-induced stress susceptibility upon systemic administration, further promoting
the translational potential of the proposed research. As well, we have shown by RNAseq that DOT1L
overexpression in D2 MSNs mimics a large portion of gene expression changes induced by ELS in this cell
type, while DOT1L knockdown blocks ELS action. We will now map H3K79me2 enrichment genome-wide in
D2 MSNs by CUT&RUNseq to identify networks of genes whose altered expression by ELS is mediated by this
histone mark. We will also generate more complete open-ended proteomic and transcriptomic datasets and
characterize additional putative chromatin scars induced in NAc by ELS. Substantial preliminary data, for
example, implicate H3K27me1 as a prominent chromatin scare that predominates in D1 MSNs of male mice
only. Together, this work will characterize novel mechanisms that drive a persisting state of enhanced stress
susceptibility and offer insight into new ways of reversing such susceptibility in adulthood.

Public health relevance
PROJECTIVE NARRATIVE The objective of this grant is to study the detailed molecular and cellular mechanisms by which different forms of chronic stress alter specific types of neurons within the brain's reward circuitry. We focus on changes at the chromatin—or epigenetic—level as mediators of particularly long-lasting effects of stress exposure. These studies will provide new information concerning how chronic stress causes lifelong changes in stress susceptibility and, in turn, identify novel leads toward the development of improved treatments for stress- related disorders in humans.